Laboratory Support Services

The NIAID Division of Clinical Research (DCR) provides effective rapid response to urgent and compelling public health concerns through program-dedicated research support to NIAID activities. DCR, via a contract mechanism with Leidos Biomedical Research, Inc. provides Laboratory Support Services through state-of-art facilities to support NIAID clinical studies. These services establish immunologic profiles of patient specimens in support of the NAID intramural program commitment to AIDS clinical research and to the study of neutrophils from chronic granulomatous disease (CGD) patients. Also, this contract establishes techniques for studying antigen and antibody response to various influenza in both natural history and treatment protocols. Procedures to be performed include, but are not limited to: (i) enumeration of lymphocyte subsets; (ii) cell sorting; (iii) proliferative responses of lymphocytes to mitogens and antigens; (iv) serum/plasma biomarkers; (v) viral loads for HIV and HCV; (vi) HIV genotyping; (vii) deep sequencing, (viii) biospecimen repository. Finally, the contract supports antibody, antigen, and biomarker analyses from COVID-19 clinical studies and trials. When appropriate, testing procedures are to be performed under the auspices of Clinical Laboratory Improvement Amendments CLIA. DCR maintains rigorous quality assurance and quality control standards, organizes and helps analyze data generated from its studies, and helps prepare these data for presentation and publication. During FY21, the NIAID DCR Laboratory Support Services provided lab services to support the conduct of approximately 80 clinical trials for the Clinical Services Program (CSP).